Integrative modelling of single-cell data to elucidate the genetic architecture of complex disease

PROJECT SUMMARY/ABSTRACT
Leveraging Genome Wide Association Studies (GWAS) to understand disease has proven challenging, as the
underlying biological mechanisms are often poorly captured by bulk tissues. Recent advances in single-cell
sequencing have led to a torrent of data across multiple modalities, contexts, and individuals, which provide an
unprecedented opportunity to understand disease biology at high resolution. We hypothesize that the fine-
scale cellular contexts captured by single-cell data will be effective at explaining disease heritability and fine-
mapping disease mechanisms. However, current approaches to integrate single-cell data with GWAS largely
rely on off-the-shelf approaches developed for bulk sequencing, which obscure the rich phenotypic diversity
present in individual cells within and across canonical cell types. The sparse and highly variable nature of
single-cell data has additionally posed challenges for robustly identifying single-cell quantitative trait loci (QTL).
Single-cell data continues to increase in size and complexity, emphasizing the need for scalable integrative
modeling. Here, we propose a 5 year research plan to develop novel approaches for integrating single-cell
data with GWAS by modeling complex cellular phenotypes not captured by existing bulk approaches. Our
proposal will identify novel disease-relevant cell states; leverage multiple single-cell modalities to fine-map
disease variants and their target genes; and discover novel single-cell QTLs associated with disease. Our
specific aims are: Aim 1: Leveraging single-cell epigenetic data to identify heritable components of disease;
Aim 2: Leveraging single-cell data to fine-map disease variants and their mechanisms; Aim 3: Defining the
regulatory effects of disease variants using population-scale scRNA-seq. While our proposed approaches are
broadly applicable to common diseases, we will benchmark them on immune-related traits and
neuropsychiatric traits which we have studied extensively with bulk datasets in published work and where we
have now aggregated a large collection of relevant single-cell datasets. Our collaboration has multiple
strengths: our focus on functional data integration across multiple single-cell modalities; our broad statistical
and computational expertise; and our extensive, data-driven publication record on common disease.

Public health relevance
PROJECT NARRATIVE Genome-Wide Association Studies (GWAS) have identified thousands of common, non-coding variants associated with disease. While integration of GWAS data with gene expression from bulk tissues has uncovered some of the underlying genes and mechanisms, only a fraction of trait heritability can be explained by existing bulk datasets and the majority of GWAS loci do not colocalize with QTLs from bulk expression data. Understanding which cell types and contexts are the most relevant for a given disease – both at the level of individual loci and across the genome – is thus critical to moving from individual variants to an understanding of broader processes and, eventually, to effective interventions.